Functional assays of Plasmodium vivax DBP, EBP, and RBP2b in erythrocyte invasion in Duffy-Negative Africans

Project Summary
Title: Plasmodium vivax Erythrocyte Invasion Mechanisms and Humoral Immune
Response in Duffy Negative Africans
Individuals of African ancestry are thought to be protected from Plasmodium vivax
infection because they lack Duffy antigen expression on the surface of their erythrocytes
rendering P. vivax unable to invade their red blood cells. However, an increasing number
of P. vivax cases reported across Africa and in Duffy-negative individuals challenges this
conventional dogma, raising the possibility that that some lineages of P. vivax may have
evolved to use ligands other than Duffy Binding Protein for erythrocyte invasion. The
intrinsic invasion mechanism and immune response of Duffy-negative individuals to P.
vivax infections are largely unknown. In this application, we will investigate the
expression and function of erythrocyte binding genes in Duffy-negative P. vivax
and the antibody response of Duffy-negative individuals to P. vivax invasion
proteins. There are three specific aims: 1) to identify genes with differential expression
between Duffy-positive and Duffy-negative P. vivax by RNA-seq; 2) to determine in vitro
binding and invasion activities of P. vivax ligand proteins identified from Aim 1 to Duffy-
negative red blood cells; and 3) to examine in vivo antibody levels to targeted P. vivax
antigens associated with erythrocyte invasion in Duffy-negative patients. As our study
sites in Ethiopia have a large number of P. vivax cases and a significant proportion
of Duffy-negative individuals, we have a unique opportunity to study the invasion
mechanisms of P. vivax in Africa and fill critical knowledge gaps in how this
phenomenon occurs. Our established lab culture facility close to the health centers
and successful P. vivax transcriptome data obtained from cultured schizonts have
demonstrated the feasibility of the proposed research. Comparison of P. vivax
transcriptomes between Duffy-negative and Duffy-positive individuals will provide the first
description of the genetic and functional attributes of P. vivax that permit infection of Duffy-
negative erythrocytes. These data will be valuable to develop molecular markers that
identify P. vivax strains able to infect Duffy-negative individuals. Such markers would
enable wide-scale screening and characterization of this phenomenon and could radically
change our understanding of P. vivax epidemiology in Africa. Further, the identification of
key ligand protein(s) P. vivax uses for Duffy-negative erythrocyte invasion and host
immune response will have important implications for P. vivax vaccine development.

Public health relevance
RELEVANCE Recent studies reported Plasmodium vivax infections in Duffy-negative individuals and that the parasites may have adapted to the African populations, but the erythrocyte invasion mechanisms are unknown. This study will examine the genetic attributes of P. vivax that permit infection of Duffy-negative erythrocytes and identify key binding protein(s) for erythrocyte invasion other than Duffy. Findings of this study will also shed lights on Duffy-negative host immune response to P. vivax infection and significantly advance our understanding of P. vivax epidemiology and distribution in Africa.